Adolescent/young adult alcohol exposure and subsequent vulnerability to stress induced anxiety

Adolescence is a critical period of neural maturation that lasts into the mid-20s in humans, ages
during which most U.S. military enlistments occur. Heavy episodic drinking is highly prevalent in
this age group, particularly among young military personnel. Recent evidence indicates
Veterans that engaged in early adolescent binge drinking (initiation before age 14) have a
higher prevalence of alcohol use disorders (AUD), substance use disorders, depression, and
stress. Risks for later development of these affective disorders in Veterans can be further
exacerbated by acute stressors, suggesting compounding mechanisms between stress and
alcohol on affective networks. However, this relationship is poorly understood and
understudied, despite its important translational implications for Veterans' health. Recent
studies in both humans and animal models have shown that adolescent/young-adult intermittent
ethanol (AIE) exposure results in enduring deficits in brain function and behavior that persist
well into adulthood and possibly for the life of the individual. We, and others, have shown these
enduring effects of AIE to include deficits in neural, glial, and neuroimmune functions in several
brain regions that are known to drive anxiety-like and other affective behaviors. Our current
preliminary data demonstrate that animals with a history of adolescent alcohol exposure are
hypersensitive to the effects of stress, inducing anxiety-like behavior. Thus, adolescent/young
adult alcohol exposure may alter limbic brain structures that predispose individuals to stress-
induced affective dysregulation long after the ethanol exposure. This suggests that Veterans
with a history of early heavy drinking may be at elevated risk for stress-induced affective
disorders. Therefore, we propose three objectives investigating rodent behavior, markers of
neurocircuitry, and synaptic function. First we will conduct rodent behavioral studies to evaluate
the anxiety- and depressive-like behaviors caused by the combination of adolescent ethanol
exposure and adult stress, their longevity, and possible pharmacological amelioration. We will
assess the role for gabapentin (Neurontin) to reverse the anxiety phenotype induced by
adolescent alcohol and adult stress and characterize the longevity of the adolescent ethanol
exposure and adult stress phenotype by testing for anxiety-like and depressive-like behavior 3
or 9 weeks after the final stressor. The second aim of the project is to identify neural circuits and
mechanisms underlying this phenotype. We propose to use transgenic Fos-LacZ rats, to assess
unbiased whole-brain anxiety-induced activation and functional connectivity to identify novel
circuits of interest involved in the etiology of the phenotype. We will investigate the
chemogenetic inhibition of the mPFC and vHipp to attenuate the anxiety phenotype. We also
propose to explore neuroimmune, neurogenesis and neurodegeneration markers, using
immunohistochemistry, in the mPFC and vHipp, and their reversal by systemic gabapentin
treatment. The third aim seeks to identify specific synaptic mechanisms underlying the
interaction of adolescent ethanol exposure and adult stress in the mPFC and vHipp via
electrophysiology and their astrocytic chemogenetic reversal. Findings from these studies will
provide clinically relevant information to inform Veterans' healthcare. Results may lead to better
methods of screening patients for mental health needs and lead to targeted treatments for
stress-related anxiety disorders that are prominent in the Veteran population.

Public health relevance
Early initiation of heavy drinking (prior to age 14) in Veterans is associated with higher rates of mental health disorders compared to other veterans and civilians. Further, military personnel aged 18-25, engage in heavy drinking at higher rates than their civilian peers, and those under 21 drink alcohol at the highest rates. Research shows that engaging in risky drinking behavior during this period induces persistent neurological changes. We have found, in a preclinical model, that adolescent alcohol exposure paired with adult stress induces an elevated anxiety- like behavior, which may be reversible. If awarded, this Career Development project will assess the persistence and pharmacological reversibility of the enhanced anxiety response to adult stress after adolescent alcohol exposure. We will also evaluate the neural circuits, neural and astrocytic mechanisms, and synaptic functions that underly these effects.